AGE-RELATED STRUCTURAL AND FUNCTIONAL NEURAL CHANGES ON COGNITIVE MEASURES

DESCRIPTION (provided by applicant): This is an application for a Mentored Research Scientist Development Award (K01). The goal of the proposed project is to provide the Applicant with the advanced skills needed to establish an independent program of research in cognitive aging using an integrative multi-modal neuroimaging approach to understanding age-related cognitive changes. The Applicant proposes a comprehensive training plan which combines didactic instruction with established researchers; formal coursework; participation in ongoing seminars at Columbia University; conduction of a prospective study and applied training experiences with individual advisors. Specific training goals include acquiring advanced knowledge and skill in the neurobiological mechanisms of cognitive aging: how aging impacts performance on cognitive tests of working memory and measures of cognition such as memory, processing speed and fluid ability. The training plan will be executed in coordination with an ongoing NIA-supported imaging study of cognition, learning and memory in aging (5R01AG026158) whose main goal is to explore changes in functional network recruitment when performance is challenged by task difficulty manipulation. This study does not address how underlying structural and resting blood flow patterns influence age-group functional or cognitive differences. Consequently, the study I am proposing will investigate the interrelations between age-related gray matter volume, resting cerebral blood flow, and functional activity. The goal of this study will be to assess whether resting blood flow and gray matter volume are independent or concomitant predictors of functional reorganization and to determine how changes in these measures mediate the relationship between age and cognition. The proposed project aims will therefore elucidate the interrelationships between multiple measures of neurobiological changes associated with aging and will serve as a bridge for the Applicant to establish an independent investigator career in conducting multi-modal neuroimaging studies in aging populations.

Public health relevance
PUBLIC HEALTH RELEVANCE: Currently, many approaches (functional or structural neuroimaging, behavioral or neuropsychological testing) to aging research are performed independently thus diminishing their impact on understanding the overall effects of normal aging on the brain. The current research proposal integrates measures of neural activity (functional activations) and underlying brain structure (cerebral blood flow and brain tissue volume) to study their influences on the relationship between advancing age and decreased performance on cognitive tests. PROJECT NARRATIVE Currently, many approaches (functional or structural neuroimaging, behavioral or neuropsychological testing) to aging research are performed independently thus diminishing their impact on understanding the over all effects of normal aging on the brain. The current research proposal integrates measures of neural activity (functional activations) and underlying brain structure (cerebral blood flow and brain tissue volume) to study their influences on the relationship between advancing age and decreased performance on cognitive tests. __SpecificAimsTextDelimiter__ Statement of Specific Aims and Hypotheses The purpose of this study is to investigate the neural basis of age-associated cognitive decline by relating multiple neural imaging and cognitive measures. In previous work, we demonstrated differences in the networks of functional activity used by older versus younger adults when performing a delayed item recognition (DIR) working memory task. During information encoding and recognition, older adults used the same brain networks as young adults. In contrast, during the rehearsal period there was evidence of functional reorganization in the elders. Functional reorganization is being defined as functional activity by the older adults in brain regions beyond what both age groups use in common to perform the task. Elders who showed the greatest utilization of additional areas, mainly comprised of the parahippocampal cortex (PHC) also performed the most poorly on the task. In a subsequent analysis, I found that increased expression of these additional areas correlated with decreased gray matter volume (GMV) within the pre-central gyrus region of the common rehearsal network. This finding suggests that due to GMV loss, older adults were forced to compensate by using additional functional resources to perform the task, resulting in decreased cognitive task performance. We hypothesized that decreased structural integrity within the rehearsal network interfered with subvocal articulation, resulting in the use of compensatory functional mechanisms. This hypothesis is consistent with work demonstrating that interference of subvocal articulation during the rehearsal phase of a DIR task results in reactivation of the initial memory information through the use of the PHC. In this proposal, I will extend my integrative imaging approach to determine the impact that age-related changes in GMV, resting cerebral blood flow (CBF) and extent of functional reorganization have on task performance and cognition. I propose to use data from a current experiment where a non-verbal DIR task is performed by groups of young and older adults. Preliminary data suggest age-related functional reorganization is occurring during the information encoding and rehearsal phases, while a common functional network is used by both age groups during the recognition phase. I propose to investigate the interactions between GMV, resting CBF and functional activity in order to test whether age-related changes in resting CBF and GMV are independent or concomitant predictors of functional reorganization, and determine how these changes mediate the relationship between age and task performance and cognition. As a prospective pilot study I will test the above mentioned hypothesis that age-related structural changes interfere with older adult's ability to subvocally rehearse verbal information, thus resulting in reliance on the PHC to trigger reactivation of the memory information. Aim 1: To test whether there are direct relationships between age, GMV, resting CBF, functional reorganization, task performance and cognition (defined as factors related to: memory, processing speed and fluid ability). Hypothesis 1A: Based on our previous finding that advancing age was related to decreased GMV, which was related to increased functional reorganization, culminating in decreased task performance, we expect to replicate this finding and extend it to measures of cognition. Hypothesis 1B: Individual differences in task performance and cognition will be partially explained by the relationships between age, resting CBF and extent of functional reorganization. Hypothesis 1C: Individual differences in task performance and cognition will be better explained with both structural and CBF information combined with age and extent of functional reorganization than either measure alone. Aim 2: To examine if compensatory functional activity found while older adults retain verbal information is the result of subvocal articulation interference similar to that from young adults retaining verbal information in the face of external interference. Hypothesis 2A: The young group will attempt to reactivate off line memory information during external interference of subvocal rehearsal as evidenced by increased PHC activity. Hypothesis 2B: Age-related structural changes will compromise the rehearsal process in the older adults, requiring this group to reactivate the memory information via PHC recruitment, even in the absence of external interference, similar to the activation patterns in the young group in the presence of the external interference. Hypothesis 2C: In older adults, the degree of structural integrity within the functional network used during rehearsal will be associated with the need to reactivate the memory information via PHC recruitment.